Characterization of POLQ's Function in Replication Rescue

Project Summary
Genomic instability is a hallmark of cancer known to generate genetic alterations during cell division. It alone
can drive oncogenesis and evolve cancer cells that no longer “play by the rules”. This is accomplished via
introduction of key mutations in tumor suppressor and cell cycle checkpoint genes that allow cancer cells to
resist many therapeutic interventions. Notably, the standard of care for many cancers is treatment with DNA
damaging agents – chemotherapeutics and radiation therapy – with the goal of damaging cancer cells beyond
repair. Thus, understanding the mechanisms by which DNA damage is repaired under these conditions is of the
upmost importance for both cancer prevention and its treatment. Amongst DNA damage, the most severe threat
to the genome are DNA double strand breaks (DSBs). DSBs have 3 major repair mechanisms which can be
deployed in response to their accumulation – homologous recombination (HR), classical non-homologous end-
joining, and Theta-mediated end-joining (TMEJ). The latter is upregulated in many cancers, specifically those in
which HR genes are mutated (BRCA1/2, PALB2, etc.). However, little is known about the role this pathway plays
in repairing breaks which occur during DNA replication, a cell cycle stage in which many cancer therapeutics
induce DNA damage. I propose to study the precise role the central protein in TMEJ, POLQ, plays during DNA
replication and the genomic consequences of such a role. In my preliminary work, I have established that POLQ
deficiency renders cells sensitive to both acute and prolonged Camptothecin (CPT) treatment, a Topoisomerase
I poison which induces replication fork collapse. Further, POLQ-null cells display high levels of terminally stalled
replication forks after CPT exposure, implying POLQ is capable of repairing forks for replication restart. In this
proposal, I aim to study how POLQ contributes to replication fork progression, protection, and recovery after the
induction of replicative breaks. Further, I have engineered an inducible broken replication fork reporter system,
with which I can measure the kinetics and repair signatures of individual replicative DSBs. Using these
experimental approaches, I can dissect the molecular requirements and outcomes of POLQ-mediated repair of
broken forks. Finally, I seek to elucidate the role POLQ/TMEJ plays during DNA replication in both HR-proficient
and deficient cancers which would provide mechanistic insight into cancer treatments and tumor dynamics.
Genome duplication is essential for cancer cell division and thus defining how POLQ repairs replicative breaks
and facilitates subsequent replication is essential.

Public health relevance
Project Narrative The accumulation of mutations drives both cancer development and its resistance to standard-of-care therapeutics. DNA replication is a major source of DNA damage and will generate mutations if proper and timely repair does not occur. This project investigates how an upregulated DNA repair pathway in cancer repairs replicative-induced DNA damage.